Novel device for the repair and sealing of dural perforations in minimally invasive surgery

Summary: Dura is the fibrous membrane that covers the brain and spine. Perforations in the dura (durotomy)
such as punctures, incisions or lacerations are often encountered during cranial and spinal surgery and require
repair and sealing to prevent serious and occasionally fatal complications related to leakage of cerebrospinal
fluid (CSF). Minimally invasive surgical (MIS) procedures of the brain and spine significantly limit direct repair of
durotomies by traditional methods such as suture or staple closure, due to a combination of restricted working
space and access vectors and limited field of view (constrained deployment), and the often-friable nature of the
perforated dura. PatchClamp MedTech, Inc. is developing novel devices to enable rapid, safe, and immediate
watertight repair and sealing of durotomies encountered during MIS and open craniospinal procedures. A low-
profile, single-hand disposable applicator enables the surgeon to place a tissue or synthetic graft through a
narrow MIS access port onto the inner surface of the perforated dura and secure it in place with a clasp released
onto the outer dural surface. Prototypes using high resolution 3D printed bioabsorbable subcomponents and
commercially available synthetic dural substitutes have provided proof-of-concept. In this proposal, we refine
and test the efficacy of the device under a variety of frequently encountered MIS constraints in vitro and demon-
strate a stable watertight seal in vivo. Ease of application, sealing efficacy and survey feedback from surgeons
deploying the graft in this model will guide sequential modifications and scaling of the device. Aim 1. Assess
mechanical attributes of device components and dural sealing performance in vitro in unconstrained
access. Using clinically relevant burst pressure chamber models, we will assess the following attributes: easy
loading and release of the graft from the applicator, atraumatic passage of the graft through the dural perforation
with rapid re-expansion, precise release of the extradural clasp struts, elastic reformation of the struts against
the membrane after release, measurement of the force applied by the struts to the external surface of the mem-
brane, minimum strut force to maintain stability against lateral movement, and ability to unclasp and re-position
or remove the graft after initial deployment. We will demonstrate that the deployed graft maintains a watertight
seal under escalating pulsatile pressure in comparison to current dural closure techniques. Aim 2. Assess per-
formance in vitro under constrained access conditions. We will assess visualization, access, deployment,
and sealing efficacy compared to current dural closure techniques under constrained access models simulating
MIS approaches using a lumbar soft tissue simulator with both a pressurized acrylic burst chamber as well as a
pressurized spine laminotomy model. Surgeon input will guide design iterations. Aim 3. Demonstrate sealing
performance in vivo. The refined prototype will be used to test device graft deployment and sealing compared
to conventional dural closure in an acute pig laminectomy durotomy model. Successful completion will lead to
preclinical IDE-enabling work in preparation for first-in-human trials.

Public health relevance
Narrative: Surgical perforations in the dura, the thick membrane of dense connective tissue surrounding the brain and spinal cord, require repair and sealing to prevent leakage of cerebrospinal fluid associated with serious complications such as infection, intractable headaches, or wound breakdown. Current dura repair methods such as suturing, stapling, grafts, and tissue adhesives are often ineffective at providing an immediate watertight clo- sure, resulting in poor outcomes and appreciable loss of time and money, including additional procedures and inpatient care to re-establish dural integrity. We address this problem with the PatchClamp surgical device to enable immediate watertight closure of the dura in either open or minimally invasive surgery, enabling the sur- geon ease and flexibility of application within restricted working space and access vectors, thereby reducing operating room time and expense and complications, substantial morbidity, and costs related to postoperative cerebrospinal fluid leakage.